Admin-Core

Administrative Core Abstract
The Center for Dietary Supplements and Inflammation (CDSI) COBRE is located at the School of Medicine
(SOM) affiliated with the University of South Carolina (USC). Administrative Core has been highly successful in
increasing its user base in the past 10 years. Thus, this Core will continue to build on the overwhelming success
by continuing to provide oversight on all aspects of the Center. During the past two phases, the CDSI has
‘graduated’ 12 junior faculty Research Project Leaders (RPLs) successfully and supported 26 Pilot Project
Leaders (PPLs). Also, we were able to secure a P01/PPG Center involving 3 junior faculty (RPLs) who have
graduated from the COBRE. Thus, the Administrative Core has been instrumental in overseeing the success
of faculty, developing and supporting strong Research Cores, and ensuring the sustainability of the COBRE.
The specific aims of the Administrative Core during Phase-3 are as follows:
To provide administrative leadership so that the Research Cores developed during Phases 1 and 2 can
transition into sustainable state-of-the-art core facilities that can support research in the areas of dietary
supplements and inflammation. We will continue our efforts to update the equipment and technology by applying
for new equipment grants supported by NIH and VA. To sustain the COBRE research cores, we will apply for
additional NIH P01-type grants.
1) To provide support and oversee the Pilot Project Program (PPP) with the goal of increasing the number of
diverse faculty working. It will also help colleges recruit new faculty committed towards COBRE Phase-3.
The Administrative Core will initiate two types of pilot projects: 1) Individual investigator-initiated 2)
Collaborative project involving at least 3 projects to secure NIH PPG/P01 type funding. The Administrative
Core will recruit diverse faculty and trainees in PPP.
2) To provide oversight and sustain a multi-disciplinary, collaborative research program in dietary supplements
and inflammation: The Administrative Core will provide oversight in the day-to-day management of the
Center. It will work with the Advisory Committee (AC) to help evaluate CDSI and ensure progress. It will
also ensure that all research pursued at the COBRE will conform to the Federal guidelines including
protection of human subjects and humane treatment of vertebrate animals, and data management and
sharing plan. The Administrative Core will also oversee and implement the Plan for Enhancing Diverse
Perspectives (PEDP) and the Data Management and Sharing Plan.
In summary, the overall objective of the Administrative Core is to further enhance the research infrastructure,
promote sustainability of CDSI, further increase the critical mass of diverse investigators by supporting pilot
projects, and provide oversight to all activities of the COBRE.